Administrative Core

Revised Abstract
The Administrative Core is responsible for ensuring that the ADRC functions effectively and efficiently, supporting scientific discovery while maintaining compliance with regulatory requirements. The Core provides leadership, oversight, financial management, and coordination across all ADRC activities. Additionally, it fosters collaborations, promotes resource sharing, engages with the community, and facilitates training and mentorship programs for investigators.